MagPAD: Magnetic Puncture, Access, and Delivery of Large Bore Devices to the Heart Via the Venous System

Project Summary
Minimally invasive cardio-thoracic approaches, such as transcatheter aortic valve replacement (TAVR), have
recently overtaken traditional surgical methods due to significant reductions in procedural mortality, morbidity,
and improved time to recovery. Transfemoral access of the heart via the femoral artery is the most common
approach for delivery of large bore devices such as heart valves and left ventricular assist devices (LVAD).
Despite improvements in health outcomes through transfemoral percutaneous approaches, large bore catheter
sheaths are used that cannot be inserted safely in approximately 20% of patients because of small vessel diam-
eter, diffuse atherosclerotic disease, or extensive tortuosity. Transcaval access to the heart has emerged as a
new approach to introducing large bore devices into the abdominal aorta, with the donor catheter entering from
the femoral vein and the receiver catheter entering from the radial artery, aligning in the inferior vena cava, and
crossing over to the aorta. It is vastly superior to transfemoral access due to lower pressure and increased
controllability that results from the reduced tortuosity of the venous system, reduced propensity for obstruction,
and large size of the veins. However, transcaval access is technically challenging, requiring multiple fluoroscopic
viewing angles and operators, which limits its use to specialized medical centers.
MagPAD is developing the MagPAD (Magnetic Puncture, Access, and Delivery) device, a cardiac catheter de-
livery system that uses magnets to simplify transcaval access to the heart, for large bore access through the
venous system. The system employs magnets that are embedded in the leading ends of catheters that automat-
ically aligns the catheters and brings the inferior vena cava and aorta closer in 3-dimensional space to simplify
crossover to the aorta. This has potential to substantially reduce the difficulty of the process, as it removes the
variability in time and difficulty in each procedure by eliminating the need for multiple fluoroscopic viewing angles
and potentially multiple operators that are necessary to accurately traverse the guidewire through the snare in
three-dimensions. Prior to this Phase I proposal, MagPAD has developed an early prototype catheter and
demonstrated magnetic auto-alignment in a porcine cadaveric model. The goal of this project will be to develop
a functional prototype and demonstrate feasibility for magnetic alignment, tissue approximation, and guidewire
crossover into the aorta in a live porcine model. Success with these goals will substantially lower the barrier to
adoption for transcaval procedures, expand access to more patients that are unsuitable for transfemoral TAVR,
and improve health outcomes by accessing the heart through the venous system which may reduce vascular
complications and risks of ischemia and stroke across all patients

Public health relevance
Project Narrative Percutaneous approaches for delivery of heart valves and other large bore devices are increasing due to im- proved morbidity, mortality, and recovery outcomes, but up to 20% of patients are not suitable for the most common transfemoral approach. Transcaval access of the heart is a superior approach, but it is technically challenging, which reduces widespread adoption. Herein, MagPAD will demonstrate feasibility for a magnetic auto-alignment approach that simplifies transcaval access to lower the barrier to adoption and to improve patient health outcomes associated with delivery of large bore devices to the heart.